Pathway Analysis in Mouse Model for Astrocytoma via Systems Biology Approach

High grade astrocytomas represent the most common brain malignancies with limited therapeutic options available and proven association with generally poor clinical outcomes. Improved understanding of disease etiology thus represents a promising avenue for developing innovative diagnostic and therapeutic strategies. The current proposal comprises the initial pilot phase of a broader collaborative effort among CAPR (Dr. Van Dykes Preclinical Research Center), UNC (Dr. Ryan Millers lab) and ISB (Dr. Leroy Hoods lab) to characterize molecular indicators and pathways underlying the astrocytomagenesis processes and to identify promising early prognostic markers of cancerous transformation and response to treatment. To this end, the project leverages the advantages of inducible disease initiation in the mouse, the ability to perturb and/or monitor the carcinogenesis process, and the extensive power of unbiased systems biology approach. A variety of state-of-the-art molecular technologies will monitor genome, transcriptome, proteome, and metabolom dynamics in tissues and blood serum as the disease progresses. Where possible, a cross-species data analysis will be exploited to determine the relevance of findings to human disease. During the past year, CAPR scientists developed and optimized breeding approaches to maintain the colony of one-of-a-kind inducible genetic model for high-grade astrocytoma and glioblastoma. The model features a complex genetic setup that mingles several mutant alleles to render dysfunctional pRb/p105/p130, K-ras, and PTEN/Akt pathways alone or in different combinations. The required set of assays to rapidly identify individual animals with desired allelic combinations has been designed and validates, along with multiple histology-, molecular biology-, and in vivo imaging-based clinically relevant endpoints to monitor disease progression stage. To exemplify, an upgraded approach allowing simultaneous imaging of multiple animals by MRI modality has been adopted by CAPR making feasible multiple longitudinal imaging sessions of the entire experimental cohort. In another line of experiment, the Preclinical Evaluation group of CAPR elaborated an orthotopic intracranial xenograft models employing either human glioma cell lines or primary GBM cells isolated from tumor bearing animals. These orthotopic models have been utilized in several collaborative projects aimed at bioavailability studies in brain tissue for nanotechnology compounds (e.g. paclitaxel loaded nanoemulsion, in collaboration with NCL) and drug candidates identified through in vitro screening strategies (e.g. Schweinfurthins, in collaboration with Dr. Reilly).